STUDIES OF METABOLISM IN BULIMIA NERVOSA

Bulimia nervosa is an eating disorder which is characterized by episodic binge eating of large amounts of food. The preoccupation with food and uncontrolled eating exhibited by these patients suggest that, despite their usually normal weight, they may be metabolically in a state of starvation, possibly related to their frequent weight cycling. The proposed study will test the hypothesis that patients with bulimia show energy-conserving metabolic adaptations which are seen in starvation. Preliminary studies have suggested that patients with bulimia tend to exhibit a reduced metabolic rate compared to controls. The current study will further this line of research by: (1) accurately measuring resting metabolic rate and diet-induced thermogenesis, tow components of energy expenditure, in 25 patients and 25 healthy controls; (2) measuring resting metabolic rate in the patient group post-treatment in order ascertain whether clinical recovery is accompanied by normalization of metabolic rate; (3) obtaining baseline measures of thyroid function (T3, T4, TSH), a major regulator of metabolism; (4) obtaining baseline measures of glucose and beta-hydroxybutyric acid as a reflection of short-term nutritional status. The information derived from this study will have implications for the clinical management and nutritional counselling of patients with bulimia and will advance our understanding of the etiology of this illnesses.